Influence of the Microbiome on the Natural History of Alopecia Areata

ABSTRACT
Alopecia Areata (AA) is a common autoimmune disease with a genetic predisposition and
potential environmental triggers. AA occurs when the immune system attacks the hair follicle,
resulting in hair loss. Its presentation can be characterized as inflammatory, non-scarring hair
loss that can occur as a partial (patchy alopecia, AAP), complete absence of hair on the scalp
(alopecia totalis, AT), or total loss of scalp and body hair (alopecia universalis, AU). Our lab
has extensively studied the genetics of AA, and we have recently turned our attention to the
investigation of environmental triggers that may play a crucial role in AA. The gut
microbiome has been identified as a potential trigger for the development of autoimmune
diseases in general. The intestinal microbial community in humans and other mammals is
highly complex, and its diversity contributes to several essential processes that maintain
intestinal homeostasis and health. Microbial diversity in the gut has recently emerged as a
potential immunomodulatory system with the capacity to elicit physiologic or pathologic
responses in the host. Although a complete understanding of the underlying mechanisms
remains somewhat elusive, mounting evidence suggests dysbiosis-induced disruption of the
gut epithelial barrier function and the systemic immune response as potential factors
contributing to disease. Despite the many commonalities between AA and other
autoimmune diseases, there are no longitudinal studies to date on the long-term effects of
the gut microbiome and different clinical outcomes in AA. There is an urgent need to
understand the mechanisms underlying the long-term effects of the microbiota on AA patients
in order to enhance the design of well-powered clinical trials in AA, and to provide more
effective patient care by developing new treatment modalities. In this proposal, we will conduct
an observational longitudinal study of the gut microbiome in a cohort of healthy controls as
well as AA patients, and correlate dysbiosis with disease flare or spontaneous remission. This
information will be invaluable to facilitate clinical trials design in the future by providing an
accurate assessment of the natural history of AA.

Public health relevance
NARRATIVE Alopecia Areata (AA) is a common autoimmune disease with a genetic predisposition and potential environmental factors, and the gut microbiome has been identified as a potential trigger for the development of autoimmune diseases in general and AA in particular, as shown in our preliminary data demonstrating a striking dysbiosis in the gut microbiome of AA patients. In this proposal, we will conduct an observational longitudinal study of the gut microbiome in a cohort of healthy controls as well as AA patients, and correlate dysbiosis with disease flare or spontaneous remission. One of the major goals of this longitudinal observational study is to determine the rate of spontaneous remission of AA over a one year period, in order to enhance the design of well- powered clinical trials, and to provide more effective patient care by establishing foundational knowledge about the gut microbiome in AA, which will in turn facilitate the development of new treatment modalities.